HYPOKALEMIA IN PATIENTS WITH IMPARIED UREA BIOSYNTHESIS

The purpose of this study is to learn the cause of low potassium levels in patients with the Urea Cycle Disorder argininosuccinic aciduria (arginino succinic acid lyase deficiency).